GAUCHER'S DISEASE-- BIOCHEMICAL AND CLINICAL STUDIES

Extraordinarily gratifying success has been obtained with replacement therapy in patients with Gaucher's disease. All patients who received macrophage-targeted human placental glucocerebrosidase had significant clinical benefit. The hemoglobin level rose in all patients, and within six months after initiation of therapy, the size of the spleen had decreased in all recipients. The enzyme injections were well tolerated, and none of the patients became sensitized to the preparation. Patients who received the enzyme were able to resume activities such as work or school that they had been unable to carry out before enzyme replacement. The U.S. Food and Drug Administration has approved the use of macrophage-targeted glucocerebrosidase as specific therapy for patients with Type 1 Gaucher's disease. The beneficial effect of enzyme replacement in patients with Gaucher's disease has been repeatedly confirmed by many independent investigators. We have found that the quantity of enzyme that patients require to be maintained in good health is far less than that which is initially necessary to reverse the clinical and pathologic manifestation of the disorder. Patients with milder clinical signs of the disorder improve with smaller amounts of enzyme than that required by more severely affected individuals.